Academic/Industry Partnership for Next-Generation Robotically Guided Intraoperative Ophthalmic OCT

PROJECT SUMMARY/ABSTRACT
This application brings together a highly collaborative and experienced team of ophthalmic surgeons,
engineers, and an industry partner to develop a next-generation ophthalmic microscope to maximize
visualization in the dynamic ophthalmic surgical environment. We seek to overcome limitations inherent to the
decades-old ophthalmic surgery stereomicroscope which limits the true integration of modern visualization
technologies like optical coherence tomography (OCT). Over the past decade, members of our team
developed the leading intraoperative OCT program in ophthalmic surgery in the US. Under initial R21 support,
our first-generation microscope-integrated OCT (MIOCT) design enabled live cross-sectional imaging during
surgery and has been the approach adopted by multiple vendors in current commercial offerings. Our
subsequent Bioengineering Research Partnership (BRP) funded work introduced the first live “4D” (volumetric
imaging through time) MIOCT technology which images microsurgery with micrometer-scale resolution at
several rendered volumes per second, interactively viewable by the surgeon from an arbitrary perspective
through a novel stereoscopic heads-up display. We have demonstrated and documented the performance of
these systems in hundreds of live human eye surgeries at the Duke Eye Center, with innovations and results
documented in over 100 peer-reviewed publications and hundreds of presentations by the Multiple Principal
Investigators and other team members. Our prior foundational work in intrasurgical OCT has resulted in a
state-of-the art capability; however, the technology still requires considerable effort on the part of both the
surgeon and a dedicated engineering operator. Unlike the outpatient clinic with stabilized patients, the dynamic
surgical environment currently requires a dedicated engineering operator to assist the surgeon with image
tracking and optimization to keep OCT at the surgical point of interest. Current stereomicroscopy is also
insufficient to provide the depth resolution needed to keep the OCT depth window in frame for tracking
solutions. The overall goals of this proposed project, then, are to develop a compact multi-camera array
microscope capable of supporting and tracking the surgical scene at high spatial resolution and pair it with an
active robot-based scan head to maintain the surgical point of interest in a dynamic scene. Together, these will
allow true integration with OCT, dynamically placing the OCT view where the surgeon needs it – such as for
monitoring a microneedle as it advances in depth through the retina and into the subretinal space. Each of
these developments are motivated by specific current needs in ophthalmic surgery visualization based on our
ophthalmic surgical and industry partners and will be developed through our well-established multidisciplinary
translational methodology of incorporating constant feedback between multidisciplinary team members. We
believe these developments will improve ophthalmic surgical visualization and also potentiate novel ophthalmic
and other microsurgeries not currently possible due to limitations in surgical visualization.

Public health relevance
PROJECT NARRATIVE This proposal brings together a multidisciplinary team of experts in ophthalmic imaging, surgery, robotics, and from the microscope industry to develop a next-generation ophthalmic surgical microscope. The overall five- year goals of the project are to develop novel technologies to provide live volumetric imaging during microsurgery maintained at the surgeon’s point of interest in a dynamically changing scene. We believe this technology will enable novel ophthalmic and other microsurgeries not possible due to current limitations in surgical visualization.